Characterizing the transmural nature of ulcerative colitis and its associated disease-related outcomes using intestinal ultrasound: a paradigm shift in treatment targets

PROJECT SUMMARY/ABSTRACT
Ulcerative colitis (UC) is an idiopathic chronic inflammatory condition of the large intestine. Current treatment
targets are aimed at healing the inflamed mucosa, however, most patients who achieve mucosal healing do not
have sustained remission and continue to have reduced quality of life and a variety of comorbidities. This
proposal provides a paradigm shift in the approach to UC as disease that is not mucosal, but transmural in its
nature. The broad objective of this research proposal is to test the hypothesis that transmural structural
alterations (TMA) to the bowel wall in UC lead to poor clinical outcomes as compared to UC that has a preserved
bowel wall structure. I will study this using a novel approach of in vivo assessment of the bowel by intestinal
ultrasound (IUS), and determine the predictors for TMA, the associated outcomes with such changes, and
whether these changes are reversible. If successful, this proposal will identify new therapeutic targets and
endpoints in clinical trials. To accomplish this, I propose the following specific aims: 1) Determine the predictors
of TMA to the bowel wall in patients with UC with either active or remitted mucosal inflammation. 2) Determine
disease-related outcomes of UC patients who have TMA and transmural healing (TH) of the large intestine.
3)Determine the relationship between TMA of the rectal wall and rectal function. I seek to develop a career as
an independent physician-scientist focused on outcomes research and disease modification in IBD. My career
goals require me to obtain additional training in patient-reported outcomes, longitudinal data analysis and
advanced bowel ultrasound techniques. The 5-year career development program outlined in this application will
be based at the University of Chicago, which has attained distinction in the clinical care and research of IBD and
is a leading IUS center in the US. Dr. David T. Rubin, Professor of Medicine, is my primary mentor and will
provide expertise in endpoint development and application of emerging diagnostic tools for the management of
UC. Dr. Eugene Chang, Professor of Medicine, is my co-mentor and an expert on the pathophysiology and
immunology of IBD. An interdisciplinary Advisory Committee will provide guidance for me during this
development period: Dr. John Hart, expert in IBD pathology, Dr. Mihai Giurcanu, expert in biostatistics, Dr. Maria
Abreu, established and NIH funded translational scientist in IBD with IUS experience, Dr. Corey A. Siegel, expert
in outcomes research in IBD, and Dr. Shintaro Sagami, expert in the use of US for UC. With the mentorship,
training, and resources available to me, I will be uniquely equipped to undertake an independent research career
in outcomes research in IBD by the completion of this career development award.

Public health relevance
PROJECT NARRATIVE Ulcerative colitis is a chronic inflammatory bowel disease associated with significant morbidity and gaps in treatment success. My proposal addresses the discordance between mucosal inflammation and the observation that UC is actually a transmural disease – an observation which may explain persist symptoms, comorbidities, and lack of disease control. In this proposal I will use intestinal ultrasound to characterize the transmural nature of UC, which will lead to new treatment targets for clinical practice and new endpoints for clinical trials.